Differentiating chronic sleep disruption from intermittent hypoxia in OSA on tau pathology and spread

Project Summary.
Accumulating evidence suggests that Alzheimer’s disease (AD) has a long preclinical phase, lasting years to
decades during which the accumulation of pathological proteins such as amyloid beta (Aβ) and tau can occur
prior to the appearance of overt cognitive symptoms. Obstructive sleep apnea (OSA) is one of the most common
sleep disorders and is composed of both sleep disruption (SD) and intermittent hypoxia (IH). Disentangling the
separate contributions of chronic SD and chronic IH may reveal how OSA impacts risk for AD. While the effects
of SD and IH on Aβ have been studied in both humans and animal models, less is known about the effects of SD
and IH on tau spread and propagation throughout the brain, a crucial step in the formation of neurofibrillary
tangles (NFT) throughout the brain.
Our rationale for targeting tau stems from our own findings demonstrating significant associations between
cerebrospinal fluid (CSF) concentrations of the wake-promoting neuropeptide orexin and both total and
hyperphosphorylated tau, and that individuals with OSA might show signs of MCI and AD at a younger age. In
addition, the treatment of OSA has been shown to delay the age of onset of MCI and to improve cognitive function
in AD. Although these observations and others implicate OSA in the regulation of tau in the brain they do not
establish directionality. A causal role for OSA in accelerating NFT formation would be strengthened by both
chronic SD and chronic IH in mouse models of tauopathy and forms the basis for Aim 1. Given the association
between tau and orexin, effective treatment of OSA holds particular promise in slowing the spread of tau
throughout the brain.
While hyperphosphorylation of tau is important in the formation of NFT’s, the development of AD may be
separately accelerated by the spread of tau from neuron to neuron by particular aggregate conformations, a
phenomenon that depends on activity of the seeding neuron. The locus coeruleus (LC) is a key brain region that
expresses some of the earliest tau pathology, and importantly, the LC promotes wakefulness through rostral
noradrenergic projections and is silent during sleep. Therefore, the increased neural activity of the LC during SD
or IH represents a potential mechanism by which chronic SD affects the spread of tau pathology to rostral targets.
Identifying the precise brain targets to which tau spreads from the LC and the time course over which this occurs
is addressed in Aim 2. Addressing the hyperphosphorylation and spread of tau in models with and without LC
specificity and the associated behavioral consequences on spatial, motor and fear learning as a function of
chronic sleep disruption or chronic intermittent hypoxia serves as the basis for Aims 3.

Public health relevance
Project Narrative. Alzheimer’s disease is the most common neurodegenerative disease and its current lack of effective treatment makes determining factors that may modify the disease course of paramount importance. Sleep disruption and chronic intermittent hypoxia are two factors which define obstructive sleep apnea, one of the most common sleep disorders in our aging population, but the mechanisms by which this may occur are poorly understood. The current proposal addresses the role of neural activity in a sleep/wake regulating brain structure in contributing to Alzheimer’s disease pathology.